Preventing Lung Cancer through Tobacco Cessation at FDNY

Project Summary/Abstract
Quitting smoking at any age can have significant health benefits which extend beyond its well-recognized
impact on cancer. The Fire Department of the City of New York (FDNY) World Trade Center Health Program
(WTCHP) is situated within its occupational health clinics. All participants in the FDNY WTCHP low dose
computed tomography (LDCT) lung cancer screening program have access to a free, tobacco cessation
program (typically cessation counseling plus nicotine replacement treatment). While many are now former
smokers, 36% of LDCT program participants continue to smoke. Novel strategies are needed to engage
WTCHP members who continue to smoke into evidence-based smoking cessation treatment. In the proposed
trial, participants in the FDNY WTCHP LDCT screening program who are retired from FDNY will be
randomized to receive Standard Care: a letter with information about LDCT screening and the free FDNY
Tobacco Cessation program including varenicline treatment and cessation counselling via telemedicine or
Enhanced Care: a letter informing them that they will be enrolled in the FDNY Tobacco Cessation Program
unless they opt-out, similar access to varenicline treatment, but coupled with individually-tailored telemedicine
sessions with our tobacco treatment specialist using that person’s most recent LDCT results to personalize
cessation messaging. All participants will receive varenicline “preloading,” i.e., four weeks of treatment prior to
their target quit date followed by 12 weeks of treatment, an approach shown to decrease pre-quit tobacco-
associated reward. Each of the essential elements of this Enhanced Care method: opt-out enrollment and
individually-tailored biofeedback linked to LDCT results has been shown to be effective in other settings.1-5 This
protocol is the first to combine these elements plus varenicline treatment with preloading in a randomized trial
of high-risk smokers (defined as those meeting LDCT screening criteria plus WTC exposure) who have either
not enrolled in tobacco cessation or not succeeded in previous quit attempts under Standard Care. We
hypothesize that the FDNY Enhanced Care Program will be associated with both increased enrollment and
improved rates of tobacco treatment outcomes compared with Standard Care.
Specific Aim 1: To compare enrollment (participation in a first visit with our tobacco treatment specialist) in the
FDNY Tobacco Cessation Program by Standard Care vs. Enhanced Care methods.
Specific aim 1a: To evaluate demographic and clinical characteristics associated with FDNY Tobacco
Cessation Program enrollment.
Specific Aim 2: To compare outcomes (retention to study end-date, varenicline and counseling adherence and
tobacco quit rates) in the FDNY Tobacco Cessation Program by Standard Care vs. Enhanced Care methods.
Specific Aim 2a: To evaluate demographic and clinical characteristics associated with tobacco
treatment outcomes.

Public health relevance
Project Narrative At the Fire Department of the City of New York (FDNY) World Trade Center Health Program (WTCHP), 36% of participants in our low dose computed tomography (LDCT) lung cancer screening program are current smokers, despite referral to the free FDNY Tobacco Cessation Program (Standard Care). We propose to test an Enhanced Care program which includes opt-out enrollment in our quit smoking program; tobacco cessation counseling individually tailored to LDCT results and treatment with varenicline starting 4 weeks prior to their target quit date. The proposed randomized trial will compare enrollment and cessation outcomes in Standard Care vs. Enhanced Care groups of challenging-to-treat, high-risk smokers.